Generation and Dissemination of Enhanced AI/ML-ready Prostate Cancer Imaging Datasets for Public Use

PROJECT SUMMARY
Summary of parent grant
The Advanced Technologies-National Center for Image guided Therapy (AT-NCIGT) is a research and
technology center with the mission of advancing patient care, by developing novel innovative tools for image
guided Therapy (IGT). The three technologies encompass Imaging Cancer Heterogeneity, Deep learning and
Intraoperative devices for image guided therapy which will be investigated both individually and in cross TR&D
combinations. The parent AT-NCIGT project includes development of the open source platform to support
management and analysis of imaging data collected during image-guided procedures. This platform is being
developed in one of the aims under the TRD2. The work proposed under this supplement is within the scope of
work being done in AT-NCIGT Deep Learning TRD specifically, since it is proposing to develop technology that
will support enriching the datasets collected for an application of priority for AT-NCIGT - prostate cancer - with
the metadata to make it AI/ML ready. The tools developed for harmonizing and enriching prostate cancer MRI
datasets will support integration of the platform with the latest AI/ML analysis tools and their evaluation, both by
the project investigators and by the external collaborators, while the publicly available curated dataset released
as a deliverable of the supplement will support external development of AI/ML tools in prostate cancer imaging.
Goals of the supplement project
We propose to make prostate cancer imaging data more AI/ML ready by performing the following, 1)
Automatically generate critical missing metadata regarding the type of MRI scan perform including the
modality, use of contrast, and presence of an endorectal coil, 2) Enhance public datasets and a BWH dataset
with this metadata and share the results, and 3) Demonstrate how to use the enhanced data in an AI/ML
application and distribute teaching materials. Through this project, we will be able to provide publicly available
enriched datasets in standardized formats that are suitable for AI and ML development of methods for the
detection and risk assessment of prostate cancer.

Public health relevance
PROJECT NARRATIVE In this project we will make prostate cancer imaging data sets ready for artificial intelligence (AI) and machine learning (ML) research and development. We will do this by providing important information such as the type of scan used to acquire the image, along with the use of contrast and a coil, which can be missing from MRI scans but are crucial for AI and ML methods. After, we will make the results publicly available along with tutorials on how to use and interact with the data.